Dose-Response and Context-Specific Sexual Risks amongst College Students

DESCRIPTION (provided by applicant): High-risk behaviors, such as driving after drinking and getting into a physical fight, are common on college campuses. There are clear and strong associations between alcohol consumption and increased likelihood of risky behaviors amongst college students. A dose-response model developed by Gruenewald and colleagues suggests there may be substantial differences in the level of risk associated with a specific level of alcohl consumption between typically light and heavy drinkers. Somewhat surprisingly, while a strong association between alcohol consumption and high-risk behaviors has been established, little is known about the degree to which drinking contexts may affect those risks. Furthermore, no one has quantified the distinct risks associated with (1) selection of a drinking context, (2) use of alcohol in that context, and (3) level of use in that context. The current application uses a quantitative theoretical framework to assess heterogeneity of dose-response and context-specific risks related to drinking using Safer California Colleges, a large survey data set available from a recently concluded evaluation of the impacts of environmental intervention programs on college drinking. From 2003 to 2008, 42,171 college student surveys were collected, with 79.5% of respondents reporting that they drank in the past year. We use data from 14,252 drinkers in 2003 and 2004 (pre-intervention years). Students provided data on drinking patterns, use of drinking contexts (e.g., Greek parties, parties in residence halls), characteristics of those contexts (e.g., other intoxicated persons), and high-risk behaviors (e.g., rode with a driver who was drunk). These replicated cross-sectional data provide assessments of college drinkers' use of drinking environments across 14 campuses in California. The aims of the proposed project are to (1) Determine whether college students' probability of engaging in high-risk behaviors varies by alcohol dose and (2) Quantify the extent to which high-risk behaviors vary in relation to background non-drinking risks, risks related to drinking, and level o use in different contexts. We will also examine whether context-specific risks are moderated by time spent in each context, number of persons in that context, and others' drinking levels (subjectively assessed). This information can be used to target preventive interventions to reduce access to high-risk contexts, eliminate all drinking in high-risk contexts, and/or reduce heavy drinking in high-risk contexts. Understanding the conditions under which alcohol use is most likely to lead to risky behaviors will benefit both prevention practitioners and consumers of this information, and will facilitate campus-wide efforts to intervene in specific high-risk drinkig settings (e.g., cooperative community programs to restrict off-campus access and use).

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose research to determine whether college students' probability of engaging in high-risk behaviors (e.g., riding with a driver who was drunk) varies by alcohol dose and to quantify three distinct risks due to selection of a drinking context, use of alcohol in that context, and level of use in that context. This information can be used to target preventive interventions to reduce access to high-risk contexts, eliminate all drinking in high-ris contexts, and/or reduce heavy drinking in high-risk contexts. Understanding the conditions under which alcohol use is most likely to lead to risky behaviors will benefit both prevention practitioners and consumers of this information and will aid in the development of recommendations with a much more practical edge, such as "risks are elevated when attending off-campus parties regardless of drinking level." __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS High-risk sexual behavior, defined as any behavior that increases the probability of negative consequences associated with sexual contact, is common on college campuses [1]. A substantial number of college students experience one or more negative outcomes associated with sexual risk-taking, such as pregnancy [2, 3], contracting an STD [2], and sex without the use of a condom [4] or other contraceptives [5]. Alcohol use is neither necessary nor sufficient to cause high-risk sexual behavior, but there is a clear and strong association between alcohol consumption and increased likelihood of risky sex amongst college students [1]. A national survey of college students found that heavy episodic drinkers were three times more likely to have had multiple sexual partners in the past twelve months than non-drinkers [6]. The association between drinking and risky sexual behavior may be influenced by the acute effects of intoxication, such as impaired judgment [7], or the elevated expectancies for risky sexual behavior when intoxicated [8]. Not all individuals are equally affected by consuming the same amount of alcohol. Models developed for the purpose of identifying risks related to different drinking quantities suggest there may be substantial differences in the number of alcohol-related problems associated with a given number of drinks between different types of drinkers (based on average number of weekly drinks) and between men and women [9]. Applied to college students, these models have been used to quantify the large number of problems related to moderate drinking among college drinkers [10]. We are unaware of any studies that have examined whether individual differences in alcohol dose-response specifically affect high-risk sexual behaviors. For example, an individual who typically consumes two drinks may have an increased probability of having unprotected sex if they consume four drinks on one occasion, while someone who typically consumes five drinks may not. Somewhat surprisingly, while a strong association between alcohol consumption and high-risk sexual behaviors has been established [5, 11, 12], little is known about the degree to which drinking contexts may affect these risks [13]. Certainly, exposure to sexual risks is context-dependent; the social environments where college students drink dictate contacts with other individuals. Risk exposures in drinking contexts are made up of (1) background non-drinking risks, (2) risks related to drinking, and (3) risks related to greater levels of use. From this perspective risky sexual behavior should be affected by contacts with others in social contexts (selection risks), low levels of alcohol use (drinking-related risks), and increasing risks with higher levels of use. The three separate risk exposures related to drinking contexts have never been quantified in a representative sample of college students. The current application uses a quantitative theoretical framework [9] to represent the social mechanisms related to high-risk sexual behaviors and to assess heterogeneity of dose-response and context-specific risks related to drinking. The aims of the proposed project are to: 1. Determine whether college students' probability of engaging in high-risk sexual behaviors varies by alcohol dose. 2. Quantify the extent to which high-risk sexual behaviors vary in relation to (1) selection of contexts (background non-drinking risks) (2) use of alcohol in contexts and (3) level of use in contexts (alcohol-related risks). We will also examine whether context-specific sexual risks are moderated by time spent in each context, number of persons in that context, and others' drinking levels (subjectively assessed). Analyses will be additionally conducted separately for men and women, as evidence points to potential differences in high-risk sexual behaviors between these groups [14]. To investigate these aims, we will use a large survey data set available from a recently concluded evaluation of the impacts of environmental intervention programs on college drinking ("Safer California Colleges and Universities," R01-AA012516, Dr. Robert Saltz, PI) [15]. 42,171 surveys were collected from 2003 to 2008, with 79.5% of respondents reporting they drank in the past year. We will use data from 14,252 drinkers in the pre-intervention years (2003-2004) and a holdout sample from non-intervention campuses in 2005-2008. Students provided data on drinking patterns, use of drinking contexts (e.g., Greek parties, parties in dorms), characteristics of those contexts (e.g., other intoxicated persons), drinking behaviors within contexts, and high-risk sexual behaviors within contexts (e.g., sex with a new partner). These replicated cross-sectional data provide assessments of college drinkers' use of drinking environments across 14 campuses in California. The short-term goals of the project are to assess the contributions of alcohol dose-response and context- specific risks to high-risk sexual behavior on college campuses. This quantification of distinct risks will add substantially to our understanding of student- and location-specific factors associated with high-risk sexual activity. In the long term, understanding under what conditions alcohol use is most likely to lead to risky sexual behaviors will benefit college prevention efforts [13]. Knowing which type(s) of risk contribute to high- risk sexual behaviors can guide practical prevention efforts towards (1) reducing access to high-risk contexts, (2) eliminating drinking in high-risk contexts, and/or (3) ameliorating heavy drinking in high- risk contexts. Issuing practical recommendations to college campuses that have ecological validity (e.g., "risks are elevated when attending off-campus parties regardless of drinking level") will facilitate campus-wide focused efforts to intervene in specific high-risk drinking settings.